Regulation Of Cytokine Gene Expression In Mast Cells

Given that mast cells increase increase at sites of inflammation and are located at surfaces where exposure to invading organisms may occur, we examined the Toll-like receptors expressed by cultured human mast cells and the ability to activate mast cells with TLR ligands. We found that viruses and polyI:C induced IFN-alpha and IFN-beta, in part through TLR-3. Human mast cells also expressed TLR-1, TLR-2, TLR-4, TLR-5, TLR-6, TLR-7, and TLR-9. The TLR ligands LPS, peptidoglycan, and flagellin induced the production of TNF, IL-1-beta, IL-5, and GM-CSF. IFN-alpha production involved nuclear factor-kappaB, p38; and C-Jun NH2-terminal kinase and mitogen-activated protein kinase. IFN-gamma treated human mast cells express FcgammaRI. Such mast cells when exposed to heat-aggregated IgG1 degranulate and subsequently generate PGD2 and LTC4; as well as release IL-3, IL-13, GM-CSF, and TNF-alpha. No mast cell activation was observed with the addition of heat-aggregated IgG2, IgG3, or IgG4. Simultaneous activation of human mast cells with aggregated IgG and C3a led to additive degranulation.